Norepinephrine in threat prediction and PTSD

Determining what the neural substrate of anxiety is will be fundamental to understanding and thus treating
psychiatric illness. However, more precise definition of anxiety is needed to develop potential circuit
therapeutics for psychiatric disorders. Anxiety can be framed as a state of threat avoidance. Threats, and the
brain states they create, exist on a continuum from very imminent to very distant and dealing with different
kinds of threats may distinguish subtypes of anxiety behaviors. A critical challenge is to identify the neural
mechanisms that enable cognitive and affective information to be combined and utilized in emotional learning.
The primary objective of this research is to elucidate the role of norepinephrine (NE) in encoding threat
predictive signals within the frontal cortex and its subsequent impact on fear learning and emotional
processing. This project will undertake a comprehensive examination of the spatiotemporal dynamics of
noradrenergic signals in response to threat cues, aiming to unravel the microcircuit and biochemical
mechanisms influenced by NE release. Our approach integrates advanced imaging techniques, such as two-
photon calcium imaging and optogenetics, to observe the activity of noradrenergic neurons and their networks
in real time. This will allow for an unprecedented examination of the temporal and spatial patterns of NE
release and its effect on neural circuitry. Additionally, pharmacological interventions will be employed to
manipulate NE levels, providing insights into its role in modulating fear responses and emotional processing.
The broader impact of this research lies in its potential to significantly advance our understanding of the
neurobiological underpinnings of fear and anxiety disorders. By dissecting the NE system's role in threat
prediction, the findings could pave the way for novel therapeutic approaches targeting NE modulation in
conditions like PTSD and generalized anxiety disorder. This research holds promise not only for enhancing our
fundamental knowledge of the brain's response to fear and threat but also for improving public health by
informing the development of more effective treatments for anxiety-related disorders.

Public health relevance
There is substantial evidence for a role of norepinephrine neurons in anxiety and PTSD. Yet substantial gaps exist in our understanding of how these neurons precisely respond to information about danger and then transmit this information to the brain. The goal of this project is to identify the substrates for threatening information inside these neurons using next-generation optical, electrophysiological and computational tools, in order to develop improved treatments for these disorders.